THE IMPACT OF GENETIC DETERMINANTS OF FENOFIBRATE'S PHARMACOGENETICS ON LIPID RE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The central hypothesis for this study is that genetic variations in UDP-glucuronosyltransferases (UGTs) contribute to fenofibrate's highly variable effect on serum triglycerides (TGs). To test this, we will screen a population for specific single nucleotide polymorphisms (SNPs) which influence UGT activity and re-recruit subjects to test the impact of high and low UGT activity haplotypes on drug disposition and TG response.